PILOT CORE

Core C will continue to oversee the execution and development of pilot projects that bring new technologies and new investigators into the Neurobiology of Addiction Research Center (NARC). MUSC neurosciences has undergone dramatic growth within the last 5 years that has expanded the pool of young, talented investigators in preclinical and clincal arenas. The pilot core will provide an opportunity to mentor some of these young investigators into the field of addiction under the supervision of senior NARC investigators. Due to the success of pilot clinical trials during the current funding period Dr. Robert Malcolm has been appointed as co-PL of Core C in order to help recruit and mentor clinical addiction investigators. Preclinical and clinical pilot projects will be solicited by advertisement and word-of-mouth and will be competitvely reviewed by the NARC Internal Steering Committee. Once funded, the progress of projects will undergo extensive monitoring by the Core Director and Clinical co-Director and the Internal Steering Committee. As in the past, the proposed pilot grants will be evaluated and prioritized to promote primarily young investigators whose work will synergize with the overall NARC mission.